Next-Generation Engineered NK Cell Immunotherapy for Ovarian Cancer

Project 2 SUMMARY/ ABSTRACT
Ovarian cancer is the second most common gynecologic malignancy and remains the leading cause of
gynecologic cancer deaths in the US. Therefore, there is a critical unmet need for new treatment options.
Chimeric antigen receptor (CAR) T-cell therapy has led to a paradigm shift in some hematologic cancers, but
efficacy in solid tumors remains limited, partly due to the lack of highly specific targets and immunosuppression
in the tumor microenvironment (TME). Moreover, the time and high cost of manufacturing autologous cell
products, and the toxicity challenges related to CAR T-cell therapy call for novel products that are universal,
safe, and potent. There is growing interest in using natural killer (NK) cells for CAR engineering since they have
an innate ability to kill tumor cells and they are safe in the allogeneic setting. In a first-in-human study, our group
showed the safety and efficacy of cord blood (CB)-derived CAR-NK cells targeting CD19 in patients with B-
lymphoid malignancies. This proposal aims to build on this platform to develop the next-generation NK cell
therapies for ovarian cancer by enhancing NK cell potency and persistence through optimal co-stimulatory
signaling, cytokine armoring and checkpoint inhibition. We have identified TROP2 as a promising therapeutic
target in platinum-resistant ovarian cancer and developed a novel strategy to target TROP2 by genetically
modifying CB-NK cells with a retroviral vector that incorporates the genes for (i) the humanized RS7 single chain
variable fragment targeting TROP2; (ii) DAP10 as an NK-specific co-stimulatory domain; (iii) IL-15 to support
their survival and proliferation; and (iv) inducible caspase-9 (iC9) as a safety switch (iC9/TROP2CAR/IL-15). Our
preliminary data show the efficacy and safety of this approach in vitro and in vivo and support its translation to
the clinic. In addition, we have developed a robust strategy to cryopreserve CAR-NK cells, allowing for the
generation of a biobank of off-the-shelf engineered NK cells that could be thawed and infused at bedside, thus
reducing cost and increasing accessibility. Finally, we have devised a novel strategy to target the immune
metabolic checkpoint CREM to modulate the metabolic fitness and potency of CAR-NK cells in the acidic TME.
We hypothesize that targeting TROP2 with iC9/TROP2CAR/IL-15 NK cells will greatly improve outcomes for
platinum-resistant ovarian cancer and that by targeting the metabolic immune checkpoint CREM we can further
enhance the fitness and potency of NK cells. We will test our hypothesis in three specific aims: In Aim 1 we will
conduct a Phase I/II clinical trial to test the safety and efficacy of intraperitoneally delivered iC9/TROP2CAR/IL-
15 NK cells in patients with TROP2+ platinum-resistant ovarian cancer (Protocol 2022-0687). In Aim 2 we will
apply innovative single-cell proteomic and transcriptomic studies to comprehensively characterize the fate of the
adoptively transferred CAR-NK cells, their interaction with the peritoneal TME, and key mechanisms of efficacy
and resistance. In Aim 3 we will perform mechanistic studies to elucidate how CREM deletion enhances the
metabolic fitness of CAR-NK cells and pre-IND studies in preparation for the next-generation clinical studies.

Public health relevance
Project 2 NARRATIVE We identified TROP2 as a highly promising and safe therapeutic target for CAR-NK therapy against ovarian cancer based on extensive preclinical and pre-IND studies. Here, we propose a Phase I/II clinical trial to test the safety and efficacy of TROP2-targeting CAR-NK cells in platinum-resistant ovarian cancer. In addition, we propose to develop the next-generation TROP2-targeting CAR-NK cells by silencing the metabolic checkpoint CREM to further enhance their potency and metabolic fitness.